A Dyadic Sleep Intervention for Alzheimer's Disease Patients and Their Caregivers

Project Summary/Abstract
Yeonsu Song, PhD, RN, FNP-C is an Assistant Professor at School of Nursing at UCLA with join appointment
at David Geffen School of Medicine. She is fully committed to becoming an independently funded investigator
specializing in sleep in individuals with cognitive impairments such as Alzheimer’s disease (AD) and their
caregivers. She has a particular interest in testing a dyadic sleep intervention program for AD patients and their
informal caregivers.
Career development and training plan: During this 1-year extended K award, Dr. Song will continue to work
with her mentors to complete training activities disrupted by the COVID-19 pandemic related restrictions. Core
training activities will include (1) refining skills necessary to deliver a dyadic sleep intervention program both in
in-person and telehealth delivery modalities, (2) enhancing skills in recruitment, particularly using virtual
strategies, (3) obtaining new knowledge of associations between inflammation and sleep among Alzheimer’s
caregivers by analyzing her research study data, and (4) refining career development skills. The mentoring
team is comprised of Drs. Jennifer Martin (expert in behavioral sleep interventions), Cathy Alessi (expert in
sleep medicine), Michael Irwin (expert in inflammatory factors), and Edmond Teng (expert in assessment of
AD). She will continue to draw on resources available at UCLA and the VAGLAHS. Her training plan features
carefully curated coursework and hands-on training experiences, all aligned with her training goals.
Research plan: This extended funding will ensure Dr. Song to successfully achieve all study aims as planned
in her original proposal. In Stage 1A (Aim 1), she already iteratively refined and finalized the dyadic sleep
intervention program targeting both members of the dyad (patients and caregivers). In Stage 1B (Aims 2-4),
she has been pilot-testing the program effects by assessing sleep, health, and quality of life in both members
of the group using a small randomized controlled trial design. The dyadic sleep intervention program consists
of one hour, 5 weekly sessions, which include manualized sleep hygiene recommendations and a behavioral
sleep intervention including sleep compression therapy. A unique aspect of the proposed work is that the
program is tailored to address sleep problems of both patients and caregivers, and includes upstream
inflammatory biomarkers among caregivers to evaluate a key mechanism of intervention benefits that can be
further explored in future research. Over the past years, she has randomized 25 dyads in this study. During the
extended award, Dr. Song will randomize additional 15 dyads thus, analyze the data of 40 dyads. Skills
developed from executing all training and research plan will enable Dr. Song to become an independent
researcher and a leader in research on managing sleep in AD patients and their caregivers, with the goal of
improving their health and quality of life.

Public health relevance
Project Narrative/Relevance to Public Health Poor sleep in both Alzheimer’s disease (AD) patients and their caregivers is associated with adverse health outcomes, and increases risk of institutionalization in individuals with AD. This proposal will pilot test an innovative sleep intervention targeting both members of dyads simultaneously. Improved sleep in AD patients and their caregivers may improve health and quality of life, and prevent or delay admission of AD patients to institutional settings, potentially leading to decreased healthcare costs.